Pilot & Feasibility Program

Abstract - Pilot and Feasibility Program
The mission of the Pilot and Feasibility (P&F) Program is to foster the development of new investigators and to
provide seed support for innovative high-risk diabetes-related research. Dr. Peter Tontonoz assumed the
directorship in 2014 and will continue to lead the P&F program in the next cycle. The UCSD/UCLA DRC has
an exemplary track record of funding catalytic diabetes research. In the history of our DRC, the P&F Program
has funded 82 projects (61 over the last 10 years). Over 90% of these were projects from young investigators
looking to establish new independent diabetes research programs. More than 95% of our P&F recipients are
still active in diabetes research, providing clear evidence that we are selecting meritorious recipients.
Moreover, our P&F-funded investigators have an impressive record of obtaining post-P&F NIH grant support
and of publications in high impact journals. Most importantly, many prior UCSD/UCLA DRC P&F awardees are
now independent, productive R01-funded faculty members at UCSD/UCLA or at other institutions around the
US. Collectively, these achievements underscore the exceptional pipeline of young investigators in our
research community and our ability to successfully identify meritorious recipients. Specific Objectives for the
P&F Program are to continue to: 1. Promote emerging and innovative diabetes projects and catalyze
development of future scientific leaders; 2. Inform and engage diabetes research communities regarding the
DRC P&F and its opportunities; 3. Mentor P&F recipients in order to facilitate and accelerate their transition to
independent external funding; 4. Leverage institutional investments in the form of matching support,
infrastructure outlays, and the development of technologies towards the success of P&F projects; 5. Synergize
with other institutional training and research programs; 6. Foster collaborative research among junior and
senior scientists, promote leadership skills, and encourage entrepreneurship and the development of
intellectual property; 7. Implement oversight and programmatic review of the P&F program and its awardees